The role of the intracellular complement system - the complosome - in monocytes

We have recently (February 2017) moved laboratories from London to the NIH. While working here, we have obtained data defining the pathways by which intracellular C5 is activated in human T cells and monocytes and have shown that this intracellular C5 activation is critical to IL-1b production by T cells/monocytes. We are currently assessing the in vivo biological significance of this observation using appropriate CVD mouse models. We are also testing the effects of cell-permeable C5 inhibitors in vitro with an eye on the development of preclinical models.